Metallobiochemistry of Mn/Fe protein cofactors

Project Summary/Abstract
This research program will establish the fundamental chemical principles underlying the newly discovered
Mn/Fe proteins. The active sites of these proteins defy conventional inorganic wisdom to spontaneously
assemble a bimetallic cofactor that contains two different transition metals in nearly identical coordination
environments. Following assembly, oxygen is activated across the metal centers to induce a one-­ or two-­
electron oxidation reaction, with regeneration occurring via intermolecular electron transfer. Unlike the well-­
studied diiron enzyme homologs, the molecular-­level details of these processes in Mn/Fe proteins remain
unknown. Because Mn/Fe-­containing proteins have been identified primarily in extremophilic and pathogenic
organisms, including many species of Chlamydia and Mycobacteria, it has been suggested that the
heterobimetallic cofactor may offer resistance against reactive nitrogen and/or oxygen species generated by
the host immune system. The proposed studies will probe this hypothesis using the R2lox proteins as a model
scaffold, examining reactivity of the Mn/Fe cofactor relative to a diiron site. Initial studies by the PI have
indicated aerobic assembly of R2lox proceeds through two distinct intermediates, identified by time-­resolved
optical and EPR spectroscopy. The proposed work will use an array of spectroscopic techniques, including
optical, resonance Raman, CW-­ and pulsed EPR, and Mössbauer, to elucidate the electronic and geometric
structures of these intermediates. Targeted mutagenesis around the active site will allow identification of key
residues responsible for selective metal binding, ultimately revealing the mechanism by which assembly and
activation proceed. To gain a comprehensive picture of the processes occurring at the active site, the redox
properties of Mn/Fe cofactors will be characterized to determine the thermodynamics and kinetics of electron
transfer, a necessary component for efficient catalysis. Finally, the scope of reactivity of Mn/Fe proteins will be
expanded using protein engineering techniques. Rational metalloprotein design will be coupled with directed
evolution approaches to generate highly active enzymes capable of selective oxidation of targeted substrates.
Collectively, the proposed research program will fill many existing knowledge gaps about the Mn/Fe proteins,
better resolving the physiological role that these unique cofactors may play in the metallobiochemistry of
microbes.

Public health relevance
Project Narrative This program will investigate the fundamental chemical properties of heterobimetallic Mn/Fe proteins, which represent an entirely new class of metalloprotein cofactor. Primary goals of this research program are to elucidate how metal selection, oxygen binding, electron transfer, and substrate oxidation are controlled. Because Mn/Fe proteins are prevalent in pathogens such as Chlamydia trachomatis and Mycobacterium tuberculosis, this work will lead to an understanding of the role these proteins play in bacterial virulence, ultimately providing strategies for development of selective and targeted therapeutics.